CORE--MONOCLONAL ANTIBODY FACILITY

The core proposal is a request to fund a central monoclonal antibody facility at Scripps Clinic and Research Foundation, to provide travel funds for travel between San Diego and Seattle, and to support a Clinic Coordinator at the University of Washington, Harborview Medical Center.